Retinal Circuitry

Connectomes are Rosetta Stones for discovering how retinas are wired, and revealing how that wiring
becomes corrupted in disease. This proposal is crafted around assembly, annotation and analysis of
ultrastructural connectomes from normal human retina, providing a normal circuit topology framework to
compare against companion human retinal patho-connectomes from human retinitis pigmentosa (RP) and age-
related macular degeneration (AMD), hypothesizing that 1) new networks including rod-cone crossover, bipolar
cell coupling, nested inhibition, and neurogliovascular (NGV) architectures, structures (cistern synapses,
plaques, adherens) are common across mammalians, and 2) seeks to explore how these network topologies
are altered in retinal disease. Prior work unmasked unexpected, pervasive complexities in mammalian retina,
informing modeling of retinal prosthetics.
Speciﬁc Aim 1. Construction / annotation of a ~100 TB connectome for human (H-RC3). Signiﬁcance. H-RC3
allows analyses of human cone channels, describing how these networks are blended with existing channels.
We hypothesize 1) novel crossover / coupling motifs are present in both midget and diffuse bipolar cells and 2)
nested feedback/feedforward architectures are key to midget pathways. With TEM-compliant molecular
markers, we will map the heterocellular architecture of the human NGV system in comparison with RC1 and M-
RC2.
Speciﬁc Aim 2. Construction / initial annotation of 2 ~50TB connectomes of human RP retina (HRPC1,2-
RC4,5). Signiﬁcance. Annotation/analysis of RC1 revealed unexpected retinal architectures inﬂuencing all
networks: refactored IPL lamination, extensive rod-cone bipolar-amacrine crossover networks, complex
homocellular / heterocellular / in-class / cross class coupling, selective bipolar cell loading by ganglion cells.
Presuming these networks are present in humans, direct comparisons from SA 1 should establish how
networks are altered in human RP, serving as guides to understanding RP progression, and reveal targets for
therapeutic intervention.
Speciﬁc Aim 3. Construction / initial annotation of 1 ~80TB connectome of human AMD retina (HRPC3-RC6).
Signiﬁcance. HRPC3-RC6 will allow exploration of altered neuronal, glial and vascular networks in AMD,
exploring whether retinal remodeling and plasticity are similar for different retinal disease mechanisms. We
now know retinal remodeling occurs in AMD, and that GABAergic amacrine cell networks are involved. We do
not know if the rules behind retinal network alterations are similar across disease proﬁles such as RP. Early
evidence suggests photoreceptor degeneration, remodeling and progressive neural atrophy are separate
processes. Testing this in non-RP models will guide understanding and create a complete connectome
database of AMD retina that includes the choroid, neural and glial components.

Public health relevance
This proposal is based on the new technologies of connectomics and graph mathematics to build complete maps of retinal nerve cells, retinal blood vessels, and their communication rules in normal human and diseased human retinas. These maps will provide a fundamental framework for understanding normal vision and events underlying retinal disease, especially how we might repair retinal degenerations such as retinitis pigmentosa and age-related macular degeneration.